The RCMI Program in Health Disparities Research at Meharry Medical College

The RCMI Program in Health Disparities Research at Meharry Medical College (RHDR@MMC)
proposes to address health disparities at multiples scales of research: from micro to macro
environments. With strengthened institutional collaboration and support, this renewal application
seeks to expand the long-term RCMI support of enabling high quality basic, behavioral, and
clinical research to eliminate health disparities as our long-term goal. The RHDR@MMC focuses
on diseases that negatively impact on minority health. The center uses interdisciplinary
approaches to engage in highly innovative research focusing on strategies that emphasize
disruption of disparity at all levels, from proteins to the human populations and the communities
Meharry serves. Our newly established one-stop state-of-art Meharry RCMI Research Capacity
Core (MRRCC) will provide expert innovative technical support in areas relevant to the research
projects, as well as services such as design, biostatistics, data science/genomic and CRISPR-
Cas9 , biologic and health informatics, and cross-training support to benefit the entire researchers
at Meharry. Furthermore, our reinvigorated Investigator Development Core (IDC) will enhance
development of Early-State-Investigators. Likewise, redesigned Meharry Community
Engagement Core (MCEC) will further enhance our ability to significantly contribute towards
understanding and reducing health disparities impact. We have assembled a cadre of resolute
scientists including basic, behavioral, data science, dental clinicians, population-based, and
community-engaged researchers at Meharry to participate in this endeavor. Our aims are to:
1. Support three outstanding research projects focusing on addressing heath disparities by
examining the neuropsychiatric effects of HIV-1 integrase inhibitors, risk factors for racial
disparities in adverse perinatal outcomes affecting African American Women and
assessment of survivor and provider perception of trauma and violence informed care
among Black Women.
2. Strengthen core technologies and expand bioinformatics, biostatistical, data science, and
core tissue culture services supporting the three research projects, as well as all Meharry
research faculty, to increase institutional success in extramural funding studying diseases
that disproportionally affect minority and other health disparity populations.
3. Nurture and enrich an environment conducive to developing new and early career
investigators by facilitating a mentorship network, enhancing professional developmental
activities, and providing pilot project funds.
4. Improve and expand relationships with community-based organizations that partner with
Meharry.
The RHDR@MMC) is designed to address health disparities through research in diseases that
affect the community it serves, engagement of this community in its solutions, and creating
technologies and research infrastructure to serve the institutional scientific community and its
academic and community partners. This collaborative approach to finding the right answers to
address disparities in health equity involves team effort including Meharry’s investigators.

Public health relevance
The RCMI Program in Health Disparities Research is designed to address health disparities through research in diseases that affect the community it serves, engagement of this community in its solutions, and creating technologies and research infrastructure to serve the institutional scientific community and its academic and community partners. This collaborative approach is of vital importance because finding the right answers to address disparities in health equity involves all of us.